Silver Telluride Nanoparticle Dual-Energy Mammography Contrast Agents For Breast Cancer Screening

PROJECT SUMMARY
Breast cancer is the most common type of cancer for women. In addition, it leads to the second highest
number of cancer deaths in women. Breast cancer screening programs using mammography and related
methods reduce deaths from this disease due to early detection and are cost-effective. However, the
effectiveness of mammography in women with dense breasts (which amount to about 10% of women) is poor.
Furthermore, this population are independently at a higher risk of breast cancer. As a consequence, women
with dense breasts are recommended to receive supplemental screening via other imaging methods.
Dual-energy mammography (also known as contrast-enhanced mammography) is a supplemental screening
technique that has high sensitivity and high specificity for breast cancer detection in women with dense
breasts. Other imaging methods can be used for breast cancer supplemental screening, such as contrast-
enhanced MRI, however, it faces challenges with reimbursement, issues of access and a high false positive
rate. Dual-energy mammography is currently done with iodine-based contrast agents that are not well
designed for this purpose, such as a very narrow imaging window, relatively low tumor to background ratio and
allergic reactions. Novel contrast agents that addressed these issues would be highly appealing.
We have recently developed silver telluride nanoparticle contrast agents for breast cancer screening via dual-
energy mammography. These nanoparticles generate strong contrast for dual-energy mammography, provide
a sustained imaging window, are highly stable and biocompatible and have best-in-class renal clearance. In
order to advance these agents towards clinical translation, we will undertake several steps. We will adapt their
synthesis so that it can be done with microfluidic chips, which allows rapid prototyping, results in homogeneous
products and scale-up of the synthesis. We will characterize the nanoparticles formed from microfluidic chip
scale-up and test them in a model of breast cancer. We will transfer the technology to a CRO for GMP
manufacturing. With the resulting material, we will perform extensive excretion and safety studies in two
species. In addition, we will perform virtual clinical trials to inform the design of clinical trials. Moreover, we will
leverage the University of Pennsylvania's rich translational environment to assist in conducting a pre-IND
meeting and assembling an IND application. The result of these steps will be a lead formulation ready to enter
clinical trials, to enable improved detection of breast cancer and therefore lower mortality from this disease.

Public health relevance
PUBLIC HEALTH RELEVANCE Early detection of breast cancer with mammography screening reduces mortality from this disease, however, mammography is not effective for women with dense breasts. We will herein advance towards clinical translation silver-telluride nanoparticle mammography contrast agents that can be administered to women with dense breasts before their scan and should highlight any tumors present. This earlier detection should reduce mortality in this group of high-risk women.